Early Life Determinants of Child Health: A New Denver-Based Cohort

PROJECT SUMMARY/ABSTRACT Our overarching goal is to recruit and follow a new cohort of pregnant
women to implement longitudinal data collection using the ECHO Cohort Protocol, and to lead ECHO-wide
analyses that advance understanding of when and how exposures during preconception, prenatal, and
postnatal/lactational periods influence a broad range of child health outcomes. We will lead solution-oriented
science to target adverse environmental exposures that may be prevented through policy, programs, and
practices, and to identify positive influences in the preconception, prenatal, and postnatal periods that may be
promoted to mitigate health risks associated with adverse early-life exposures. We will leverage our local
investigator and staff expertise to enroll pregnant women and their children from a large Federally Qualified
Health Center in Denver, Colorado. In Aim 1, we propose to utilize the breadth of Core data elements in the
ECHO Cohort Protocol to answer solution-oriented research questions regarding the link between early-life
exposures and childhood health outcomes, and to identify modifiable prenatal and postnatal factors that may
minimize risk. In Aim 2, we propose to implement novel and scalable Specialized measures to determine
biological pathways linking parent and family lifestyle factors and the physical/chemical environment of early
life with child obesity and neurodevelopment, and to identify susceptible periods for these exposures in early
life. In Aim 3, we describe our plans to recruit and follow a cohort of over 800 pregnant women with and their
children, and to additionally enroll over 300 participants with a high probability of subsequent pregnancy into a
preconception study. In Aim 4, we propose research questions that utilize data elements collected during the
preconception period, to identify parental preconception exposures that adversely affect child health outcomes,
and to describe molecular markers that may mediate these effects. Our team of expert investigators is well-
positioned to contribute to the development of the ECHO specialized exposure and outcome protocols, and to
the design and implementation the preconception pilot study. Our experienced staff and MPI team will ensure
successful recruitment and implementation of the ECHO Cohort Protocol to provide a robust sample size and
high-quality data. We will lead ECHO-wide analyses to address pressing questions in the early-life origins of
child health and disease, and to identify potential targets for prevention of adverse environmental exposures
and for promotion of protective factors in early life.

Public health relevance
PROJECT NARRATIVE We propose to recruit a diverse cohort of pregnant people and their partners from a large hospital system in Denver, Colorado, and to implement the ECHO Cohort Protocol to collect high-quality longitudinal data on parents and offspring. Our research will leverage the exceptional data resources generated by the ECHO Program to inform policies, practices, and programs aimed at reducing environmental chemical exposures in early life, and promoting data-driven interventions to improve the health and well-being of children.